Data Management & Analysis Core

Summary/Abstract
Exposure to volatile organic compounds (VOCs) is an important determinant of maternal-offspring
health, with implications for preterm birth and associated adverse health outcomes. VOCs
contaminate shallow soils and groundwater of post-industrial cities at Superfund, residential,
commercial, and industrial properties, leading to exposures via vapor intrusion. The Center for
Leadership in Environmental Awareness and Research (CLEAR) is dedicated to understanding and
mitigating this serious environmental health problem. The Data Management and Analysis Core
(DMAC) will provide unified and integrated data and biostatistics/informatics services, while promoting
scientific synergy across the CLEAR projects and cores; we will achieve these goals by interfacing
with the CLEAR cores to advance the two environmental science and engineering research projects
(E1 and E2) and three biomedical research projects (B1–B3). The proposed DMAC will leverage over
25 years of experience serving as the Data Coordinating Center for multisite projects, including our
flexible, centralized data management infrastructure that builds on standard operating procedures,
our seamless collaboration with research scientists in designing cost- and time-efficient studies and
having data collection based on “FAIR” guiding principles (Findable, Accessible, Interoperable, and
Reusable), and our biostatistics and informatics expertise in analyzing complex data using cutting-
edge analytical methods in public health research. DMAC will ensure the success of CLEAR research
projects by: 1) Customizing a web-accessible, centralized, and secured data management system to
capture complex data to ensure data quality and timely data integration to foster data sharing and
interoperability and 2) Catalyzing CLEAR growth by working with project and core leaders to develop
new hypotheses about VOC exposures and adverse health effects based on integrated data analysis
and by collaborating with the Research Experience and Training Coordination Core to train the next
generation of environmental scientists in the principles of data collection and management.

Public health relevance
Project Narrative The Center for Leadership in Environmental Awareness and Research (CLEAR) has built an integrated, transdisciplinary framework, rooted in advanced techniques in environmental engineering and biomedical research, to address human exposures to volatile organic compounds (VOCs) and health risks—for preterm birth in particular—in urban areas. CLEAR research is expected to have a direct impact on affected communities, stakeholders, and the agencies responsible for Superfund site management and reduction of environmental VOC exposure. The Data Management and Analytics Core will provide integrated data and biostatistics/informatics services that promote scientific synergy across CLEAR projects and cores, ensure data quality assurance and quality control, and foster data sharing and interoperability.